IGF::OT::IGF SMARTT NON-BIOLOGICS AND SMALL MOLECULE PF; BASE PERIOD; FY16; AMT $ 1,175,069; CAN 8470205

The National Heart, Lung, and Blood Institute (NHLBI) provides global leadership for a research, training, and education program to promote the prevention and treatment of heart, lung, and blood diseases and enhance the health of all individuals so that they can live longer and more fulfilling lives.